Automated Assessment of Maternal Sensitivity to Infant Distress: Leveraging Wearable Sensors for Substance Use Disorder Prevention and Research

Project Summary
Decades of research have established the importance of early mother-infant interactions for lifelong adaptive
social emotional functioning, with implications for the development of later problem behaviors including sub-
stance use disorder. A history of maternal sensitivity to infant distress – that is, responses that are consistently
contingent, nurturing, and appropriate – is thought to allow infants to internalize socioemotional competencies
for maintaining states of emotional security. This is reflected in the development of secure mother-infant attach-
ment and self-regulation behaviors. In turn, mother-infant attachment security is predictive of a constellation of
behaviors in childhood and adolescence – including parent-child and parent-adolescent relationship quality,
childhood internalizing and externalizing behaviors, competence with peers, and school success – each of which
independently predict substance abuse and substance use disorder.
The objective of this proposal is to advance opportunities for research and preventative interventions for the
intergenerational transmission of substance use disorders by developing and validating mobile sensor algorithms
that can be used to remotely assess maternal sensitivity in both standardized protocols and everyday ecologi-
cally valid home interactions. Using audio recorders worn by infants and mother-infant motion and proximity
data, we will develop models that can distinguish sensitive from insensitive maternal responses to infant distress.
Critically, we develop our models with “training data” from a diverse sample of families, including families at both
high- and low- risk for substance use disorders and who speak both English and Spanish. This will ensure that
our tools will benefit the families who need them the most.
We envision that future efforts could leverage our algorithms to identify families at greatest need for existing
evidence-based interventions to improve maternal sensitivity and child outcomes. Once trained, our algorithms
could be integrated into “just in time” interventions to provide real-time feedback and progress reports for mothers
participating in interventions. Additionally, these algorithms will be invaluable to research examining the devel-
opment of challenges in early caregiving and how such challenges can become amplified over time. For example,
these tools could be used to observe the role of difficult infant characteristics, like aversive or excessive crying,
maternal stressors or substance use cravings, and maternal support systems, including paternal involvement.
As such, the innovative tools produced in the present proposal will both contribute to real-world public health
efforts and expand research on the dynamics of early child development.

Public health relevance
Project Narrative High-quality mother-infant interactions set the stage for secure parent-child attachment, self-reliance, and children’s ability to flexibly solve problems and “bounce back” from difficulties. This constellation of behaviors reduces the risk of later developing problem behaviors, including substance use. The current proposal will develop algorithms that use data from wearable sensors to assess the quality of early mother-infant interactions objectively, automatically, and remotely in natural home environments, with the goal of developing tools to facilitate identification and prevention of early risks for substance use disorders.